SenNet Supplement - 2 -FY 2024

SenNet CODCC Supplement Abstract
The purpose of the Supplement is to further the CODCC Administrative Core (Sub-Section C:
Administrative Core: Including Consortium Coordination & Outreach) in these areas:
1. supporting each of the additional (murine-focused) awards and their integration in the
consortium,
2. developing and executing a comprehensive, nationwide, underrepresented scientific
internship award program in cellular senescence based on the NIH criteria
Given the large expansion of consortium awards focused on murine data, additional support and
coordination is required to handle the rapid growth in the development of the broader overall
SenNet eco-system. This includes coordination with other single cell platforms at a larger scale
to best serve the expanded SenNet Consortium adding substantive murine focus, and the
broader research community.
Internships will allow learning valuable new skills across the scientific research spectrum and
gain experience in an educational lab environment. During the internship program, students will
conduct cutting-edge research, greatly expanding their knowledge of biology and data analysis.
Students will develop a variety of skills throughout the summer.

Public health relevance
SenNet CODCC Supplement Project Narrative The purpose of the Supplement is to further the CODCC Administrative Core in these areas: 1. integrating additional SenNet awards beyond the initial consortium; 2. executing the underrepresented scientific internship program